Tumor Cell Biology Training Program

Abstract/Summary
The goal of the Tumor Cell Biology Training Program (TCB-TP) is to equip the next generation of cancer
biologists and clinician scientists with the tools required to drive innovative biomedical research during their
careers. Despite dramatic improvements in the diagnosis and treatment of certain cancers, an intensified effort
on multiple fronts is required to continue progress toward long-term survival or cure for all cancer types. The
TCB-TP uses two complementary approaches to provide trainees with the knowledge, analytical tools, and
critical thinking skills they need to integrate diverse and rapidly evolving fields of biology and technology, as well
as insights generated by clinical researchers: 1) Training in the mechanisms of tumor initiation and progression,
and the techniques available to study these processes, and 2) Providing opportunities to directly connect insights
from basic tumor biology with the rapid evolution of cancer diagnostics and therapeutics. These objectives are
achieved through the participation of trainees and faculty with a wide range of scientific interests and expertise
in both basic and translational research. Trainee mentors are drawn from 25 Ph.D. and M.D. faculty members in
15 different UCLA departments; areas of research include cancer-initiating cells, transcriptional regulation, tumor
micro-environment, metabolism, computational biology and ‘omics analyses, and cell cycle control, as well as
disease-specific investigations, diagnostics, and drug discovery. Eight predoctoral and postdoctoral trainees are
typically supported for two-three years while they conduct mentored laboratory-based research projects. The
TCB-TP provides several additional unique training and career development opportunities for its trainees. The
centerpiece of the program is a monthly seminar course that brings together trainees and faculty to critically
discuss research data presented by each trainee, culminating in an annual symposium. Trainees are also
introduced to the multiple paths leading to new cancer diagnostics and therapeutics through the Career
Opportunities Forum in which invited speakers from industry or science publishing join the trainees for weekly
discussions during summer quarter. The New Technologies Seminar series brings invited faculty together with
trainees to discuss cutting edge technologies, with topics chosen by trainees. Trainees connect with leaders in
their field by inviting and hosting external speakers for the UCLA Jonsson Comprehensive Cancer Center
(JCCC) seminar series. One-on-one meetings between program leadership and trainees provide feedback on
seminar presentations and Individual Development Plans. Courses on grant writing, ethics, and reproducibility
in research are mandatory for all trainees. The TCB-TP is jointly directed by Dr. Gay M. Crooks and Dr. Owen
N. Witte, academic leaders at UCLA with well-established programs in basic and translational research. Internal
and external advisory committees assist with program evaluation and strategic planning. As the only cancer cell
biology training program at UCLA, the TCB-TP represents an essential and highly-connected node in the network
of cancer research on campus, the UCLA medical center, and Southern Californian biomedical research.

Public health relevance
Narrative The educational and research mission of the UCLA Tumor Cell Biology training program is to train the next generation of biomedical scientists and clinician scientists in i) the application of "cutting edge conceptual and technical strategies to cancer biology and medicine and ii) the multidisciplinary, team approaches required to apply those strategies and insights iteratively between the laboratory and the bedside.